2023 Cannabinoid Function in the CNS Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY
Cannabinoid signaling in the CNS is composed of the types 1 and 2 cannabinoid receptors and their cognate
exogenous and endogenous ligands. Cannabinoid signaling is widely distributed throughout the CNS and it
is implicated in a wide variety of important neurobiological processes including reward signaling and
addiction, regulation of energy homeostasis, learning and memory, motor function, anxiety, and social
function. Therefore, understanding the neurobiology of cannabinoid signaling could have broad implications
for physiological CNS function and the pathophysiology of neuropsychiatric disorders. The Gordon Research
Conference (GRC) on “Cannabinoid Functions in the CNS” and its associated Gordon Research Seminar
(GRS) are widely regarded as the best scientific forums in the field of cannabinoid function in the CNS. This
GRC meeting has a strong reputation for attracting the most active and renowned scientists in the field and
it is an extremely valuable meeting for trainees aiming to become the next generation of cannabinoid
neuroscientists. In this application, we request financial support to partially cover expenses for
predoctoral and postdoctoral trainees to attend the 2023 and 2025 “Cannabinoid Functions in the
CNS” GRS/GRC meetings. The primary aims of this conference are: 1) To provide outstanding scientific
programs in the traditions and spirit of the Gordon Research Conferences. These include an emphasis on
an environment that fosters inclusivity of a diverse group and the highest level of scientific enquiry in a safe
setting. The conference will include cutting-edge unpublished data by leaders in the field; a community
atmosphere that fosters informal discussion and stimulates new collaborations; and inclusion of plenary
speakers outside of the cannabinoid field who could stimulate new areas of cannabinoid research, and 2) To
foster the development of young scientists and trainees in the field. For this aim, a GRS will precede the
GRC and will focus on increasing professional networks of young scientists, providing a venue for oral
scientific presentation for trainees, and career development seminars. A second approach for this aim will
be the implementation of a mentoring system during the GRC to increase 1:1 interactions between trainees
and senior scientists in the field. The “Cannabinoid Functions in the CNS” GRS/GRC has several unique
qualities including a: 1) focus on the CNS, which is not present at any other cannabinoid-centered meeting;
2) strong emphasis on cutting-edge unpublished data; and 3) continuing commitment to trainees through
organization of the GRS, trainee mentoring program, and career development opportunities.

Public health relevance
PROJECT NARRATIVE Use of cannabis products for therapeutic and recreational purposes is increasing, as is our scientific understanding of the health and neurobiological effects of the endogenous cannabinoid signaling system in the brain. The Cannabinoid Function in the CNS Gordon Research Conference is an outstanding scientific meeting where neuroscientists and clinicians studying effects of cannabinoids can meet to share their unpublished findings, ideas, and guide the future of scientific research in this field. Here we request support to assist trainees in the field to attend and present their work in this important and stimulating venue.